Mechanisms for modulation of miRNA-mediated gene silencing

Project Summary/Abstract Project Summary/Abstract is included in the Research Strategy section.

Public health relevance
Project Narrative Project Narrative is not requested.